UNC Center for AIDS Research Core F Biostatistics

The comprehensive, long-term objectives of the Biostatistics Core are to provide state-of-the-art statistical support for HIV/AIDS-related research of the UNC CFAR. The specific aims include: (1) providing a broad spectrum of collaborative biostatistical services; (2) developing, implementing, and disseminating innovative statistical methods for HIV research; (3) facilitating intra-CFAR research, fostering inter-CFAR collaborations, and supporting NIH HIV research networks; (4) supporting Scientific Working Groups (SWG) and Research Interest Groups (RIG), training, and mentoring; (5) conducting strategic planning, evaluation, and dissemination/outreach. To achieve these aims, members of the Biostatistics Core proactively engage with UNC CFAR investigators to identify and deliver services essential for highly productive design, conduct, analysis and publication of HIV research. The Core contributes to the framing of hypotheses, development of study designs, preparation of grant applications, selection of appropriate statistical methods, and delivery of statistical analyses. Developmental Awardees, Early Stage Investigators, and experienced investigators new to HIV research receive highest priority for Core services. The Core also develops and implements innovative statistical methodologies as needed for CFAR studies. Additionally, the Core provides training and education to the CFAR research community to equip investigators with traditional as well as innovative statistical methods needed to conduct HIV related research. Strong institutional support from the UNC Department of Biostatistics allows the Core to take full advantage of existing infrastructure, resources and contacts with faculty renowned for their expertise in specialized fields of statistics. Leadership and strategic planning of the Core will be guided by consultation with the CFAR Executive Committee, surveys of the CFAR membership, an Internal Advisory Board, an External Advisory Board, and through participation in CFAR retreats.